Graph-Based Medical Image Segmentation in 3D and 4D

Efficient detection of globally optimal surfaces representing object boundaries in volumetric datasets is important and remains challenging in many medical image analysis applications. This proposal deals with a specific problem of detecting optimal single and multiple interacting surfaces in 3-D and 4-D,including cylindrical shapes, closed-surface shapes, and "complex" shapes. Novel methods allowing incorporation of shape-based a priori knowledge in the optimal surface detection framework will be developed. s The computational feasibility is accomplished by transforming the 3-D graph-searching problem to a problem of computing an optimal closed set in a weighted directed graph. Combining the global optimality with problem-specific objective functions used in the optimization process will facilitate application of the methods to a wide variety of medical image segmentation problems. We hypothesize that image segmentation based on 3-D and 4-D surface detection utilizing optimal graph searching will provide accurate and robust segmentation performance in volumetric image data from a variety of medical imaging sources, offering theoretical efficiency andpractical applicability. We propose to: 1) Develop and validate a method for optimal detection of single and multiple interacting surfaces applicable to biomedical image segmentation in 3-D and 4-D (including cylindrical and closed surfaces). 2) Develop and validate a 3-D and 4-D optimal surface detection method that preserve complex topologies. 3) Develop and validate a 3-D and 4-D optimal surface detection method that incorporates shape priors into the segmentation process. The developed methods will be tested in comparison with state-of-the-art methods utilized today. The methods' performance will be statistically assessed in data samples of sufficient sizes. Public Health relevance: Volumetric image scanners (e.g., computed tomography, magnetic resonance, ultrasound) are increasingly available in medicine, yet the analysis of spatial data is typically performed visually on a slice-by-slice basis. The large amount of volumetric information therefore cannot be fully utilized by the physicians. Image analysis methods such as proposed here allow evaluating the image data objectively in a quantitative manner, promising to substantially impact image-based clinical care.